Antihypertensive Mechanisms of Minocycline in Resistant Hypertension: Role of the gut microbiota-brain-immune axis

PROJECT SUMMARY
Hypertension (HTN) is the most prevalent modifiable risk for cardiovascular disease (CVD) and disorders
directly influencing CVD (i.e., diabetes, chronic kidney disease, obstructive sleep apnea, etc.). Despite lifestyle
changes and drug therapy advances, ~20-30% of patients with treated HTN are “resistant” to (require ≥3)
antihypertensive drugs. TRH is generally thought to originate through volume overload and autonomic nervous
system (ANS) dysfunction that impairs immune function and inflammatory response. However, few treatment
options are available for patients with TRH and promising procedures (e.g., renal artery sympathetic denervation)
remain inaccessible to most. Thus, a mechanism-based breakthrough is imperative to foster development of
novel medical-based strategies to better control blood pressure (BP) and potentially cure and/or prevent TRH.
Our prior funding period provides strong evidence for an altered gut microbiota-gut leakiness-
neuroinflammation interaction hypothesis in which gut dysbiosis and gut leakiness, combined with
neuroinflammation, perpetuate neurogenic HTN and contribute to TRH and possibly to racial disparities in TRH.
We also showed that minocycline, an antibiotic with anti-inflammatory properties, appears to reduce BP in animal
HTN models as well as among patients with TRH. In this renewal application, we propose to elucidate
mechanisms that underlie the effects of minocycline on BP-lowering in White and African American individuals
with TRH. Our overarching objective is to test the hypothesis that minocycline rebalances gut dysbiosis, namely
by increasing butyrate-producing functional capacity, attenuating gut-mediated inflammatory response and gut
leakiness, and that these effects explain BP-lowering effects in TRH.
Four specific aims are proposed to support/refute this altered gut microbiota-gut leakiness-
neuroinflammation interaction hypothesis in TRH: Aim 1 will investigate the hypothesis that minocycline alters
gut microbiota (primarily butyrate-producing capacity) that mediates minocycline-induced BP lowering in TRH.
Aim 2 will assess the extent to which minocycline alters gut-associated inflammation and gut leakiness, and their
response with BP changes after minocycline treatment. Aim 3 will evaluate the hypothesis that minocycline
reduces neuroinflammation in TRH. Aim 4 will evaluate the hypothesis that these effects of minocycline differ in
White versus African American individuals. Together, these studies will elucidate ANS-based mechanisms of
host-microbiota interactions in TRH, evaluate potential of minocycline to reduce TRH, and serve as proof of
concept for other therapeutic options that rebalance microbiota or mitigate TRH-associated inflammation, to
improve BP control in patients with TRH, who remain at high risk.

Public health relevance
PROJECT NARRATIVE Hypertension is the most prevalent risk for cardiovascular disease, diabetes, obesity, chronic kidney disease and obstructive sleep apnea and patients with “treatment-resistant hypertension,” defined by inability to achieve blood pressure control despite use of ≥3 antihypertensive drugs, are at particularly high risk of these adverse outcomes. We propose that treatment-resistant hypertension stems, at least in part, from gut dysbiosis and associated gut inflammation, neuroinflammation promoting autonomic nervous system activation, or both; and, that minocycline (an antibiotic with anti-inflammatory properties) can ameliorate these disorders. We aim to conduct a randomized clinical trial of minocycline versus placebo, to determine the extent to which these mechanisms contribute to the blood pressure-lowering effect of minocycline, and whether these mechanisms may differ in Black and White Americans.